Administrative Core

This Administrative Core provides administrative support to ensure the proper functioning and coordination of the Program Project. The Core is Lead by Keith Mostov, M.D., Ph.D., who is Principal Investigator of the Program Project and is responsible for the overall administration of the Program Project. The Administrative Core provides an Administrative Assistant to assist Dr. Mostov in coordinating the administration of this large and complex Program Project. The Core also provides a Financial Analyst, to assist in the management of the budget and other financial matters.